Regenerative Engineering of Musculoskeletal Tissues- a Convergence Doctoral Training Program

PROJECT SUMMARY / ABSTRACT
We propose a novel NIAMS doctoral T32 Program, Regenerative Engineering of Musculoskeletal
Tissues: A Convergence Doctoral Training Program, which offers inter-disciplinary research areas at
the University of Connecticut (UConn) combining biomedical science and engineering faculties.
Regenerative Engineering is defined as the Convergence of advanced materials science, stem cell
science, physics, developmental biology and clinical translation for the regeneration of complex tissues
and organ systems. The T32 Program will enroll 3 Ph.D. candidates per year and support each for 2
years of Graduate School. The students will be drawn from graduate programs at UConn (School of
Medicine and School of Engineering). The students will then apply for T32 support at the end of Year
1 of graduate school to be supported for Years 2-3. They will all receive their Ph.D. from the Graduate
School at UConn. The T32 Program will offer trainees a broad level of expertise in research and
instruction based on the research, educational, and clinical experiences of the biomedical and
engineering faculty who serve as preceptors. Trainees will become experts in regenerative engineering
and its foundations to work towards the alleviation of human disease and musculoskeletal injuries by
means of tissue regeneration. Musculoskeletal regeneration is a field ripe for an inventive approach
based on convergence to address challenging issues, advance technology and further fundamental
knowledge for therapeutic applications. At the center of the Convergence approach is the
understanding that new solutions in regeneration will take place through an `un-siloed' approach. Thus,
Regenerative Engineering welcomes ideas and research across a gamut of disciplines. The T32
Program has preceptorship commitments from 20 distinguished faculty at UConn (representing
Biomedical Engineering, Cell Biology, Computer Science, Genetics and Genome Sciences, Materials
Science, Mechanical Engineering, Molecular Biology and Biophysics, Oral Health, Orthopedic
Surgery). This eminent group of investigators is well funded and published to provide the primary
research training and serve as role models for doctoral trainees. The T32 Program goals are to
educate, support and enhance the training of individuals dedicated to careers as independent clinical
translational and basic scientists in regenerative engineering. Our Program strengths include its
interdisciplinary and collaborative research in biomedical science and engineering, interactions with
diverse trainees and faculty, training in contemporary research methodologies, and successful
preceptors. T32 Program administration through the Connecticut Convergence Institute for Translation
in Regenerative Engineering will provide the experience to recruit diverse trainees, including
minorities, implement the curriculum, and train a new cadre of convergence scientists.

Public health relevance
PUBLIC HEALTH RELEVANCE Disorders of the musculoskeletal system with advancing age or due to injury and trauma are among the most debilitating to the human body and costly to the healthcare system with disability. Novel treatments will require convergence of molecular, cellular, and organismic research through interdisciplinary integration of biomedical science and engineering. This T32 Program is based on the unique concept of training Ph.D. candidates in the realm of scientific convergence applied to the field of regenerative engineering to enable these discoveries.